Enhancing the Efficacy of T-cells and immunotherapies by precision targeting of Nrf2 using PROTACs

T-cells are key players in adaptive immunity and have revolutionized immunotherapies for cancer,
autoimmune, and infectious diseases. Manipulating T-cell functions provides a promising avenue for
precision medicine. Nuclear factor (erythroid-derived 2)-like 2 (Nrf2), a transcription factor regulating redox
balance, has emerged as a suppressor of T-cell inflammation and anti-tumor responses. Our recent
studies revealed that Nrf2 modulates T-cell expansion and metabolism, influencing immune responses.
Our preliminary data showed that while Nrf2 activation in T-cells alleviated inflammatory bowel disease
(IBD) disease pathology by suppressing inflammation, Nrf2 deficiency improved melanoma outcomes by
boosting T-cell cytotoxicity. Thus, targeting Nrf2 in T-cells could serve as a strategy to fine-tune
inflammatory and cytotoxic functions. This project aims to manipulate Nrf2 in T-cells using PROTAC
technology to either suppress inflammation in inflammatory bowel disease (IBD) or enhance anti-tumor
T-cell responses against melanoma. Instead of conventional Nrf2-targeting drugs with off-target effects,
we propose using PROTACs, which offer higher specificity, potency, and prolonged inhibition. As Aim 1,
we will develop Keap1-degrading PROTACs to activate Nrf2 in T-cells, suppressing inflammatory Th1 and
Th17 cells while enhancing regulatory T-cells (Tregs) to alleviate IBD. The efficacy of these PROTACs in
vivo will be tested in preclinical IBD models. As Aim 2, we will evaluate Nrf2-degrading PROTACs to
enhance CD8+ T-cell-mediated anti-tumor responses. The efficacy of these PROTACs will be tested
alone and in combination with checkpoint inhibitors in mouse models of melanoma. These studies will
establish PROTAC-based strategies for precise immune modulation of T-cells and utilize them in different
disease conditions.